Circular RNA aptamers to regulate iron homeostasis in iron overload disorders

SUMMARY: Iron overload disorders are caused by homeostatic imbalance of iron in the liver.
Excess iron produces reactive oxygen species that induce inflammation, fibrosis, and cause ferroptosis, an
iron-dependent form of cell death. Reducing iron levels has a therapeutic benefit. Although chelating iron is
appealing for these disorders, iron chelators exhibit poor pharmacokinetics and induce a compensatory iron
uptake response in cells. In this proposal, we are proposing a completely novel approach for removing iron
from hepatocytes. Our approach targets IRP1/2, the proteins the control iron homeostasis. IRP1/2 binds
“IRE” sequences found in certain mRNAs only when iron levels are low. IRP1/2 binding to mRNA leads to
translation of proteins that cause iron influx in cells. Since IRP1/2 is abnormally activated in iron overload
disorders, blocking the IRP1/2's RNA-binding activity could reduce intracellular iron and reduce ferroptosis.
Since IRP1/2 cannot be targeted with small molecules or siRNA due to an essential function of IRP1, we
are proposing a new therapeutic concept: we are using IRE sequences as “decoys” to block IRP1/2 from
binding mRNA, thus simulating a “high iron” state, and causing the cell to reduce cellular iron levels. This
approach would normally be impossible since small RNAs, like the IRE, are highly unstable in cells.
However, Chimerna scientists have developed a new strategy to stabilize the IRE by synthesized this RNA
as an RNA circle. We find that these circular IREs induce a robust iron removal program and cause cells to
become resistant to ferroptosis. At this point, the major question is can these circular IREs be effectively
targeted to hepatocytes and do they reach a therapeutic concentration. In order to test this idea, the
specific aims of this proposal are: (1) To optimize the delivery and dose of circular IRE RNA for
perturbing cellular iron homeostasis. We will synthesize circular IREs with a triantennary N-
acetylgalactosamine that allows the circRNAs to be preferentially taken up by the liver (2) To test the
ability of circular IREs to reduce ferroptosis in culture models of iron overload disorders. Here, we
will use an iron overload disorder model of primary human hepatocytes treated with ferric ammonium citrate
(FAC). Primary hepatocytes will be transfected with tri(GalNAc)-modified circular IREs. These
comparisons will allow us to determine whether circular IREs are as, or potentially more effective, than
standard chelator-based approaches. Overall, this application will (1) create a fundamentally new type of
RNA therapeutic; (2) target cellular iron homeostasis for the first time; and (3) provide a fundamentally new
approach to treat iron overload disorders.

Public health relevance
PROJECT NARRATIVE Iron overload disorders caused by primary or secondary hemochromatosis are highly prevalent liver disease that is associated with high levels of ferroptosis, an iron-dependent form of cell death. In this project, we will develop a new type of therapeutic comprising a circular RNA that binds and impairs the function of an RNA- binding protein that is the central regulator of intracellular iron homeostasis. We will synthesize circular RNAs with a triantennary-N-acetylgalactosamide and optimize delivery to hepatocytes. We will determine the ability of this circular RNA to reduce hepatic iron levels and prevent iron-mediated ferroptosis in hemochromatosis.